Evaluating the use of long-acting antiretroviral treatment for HIV during community re-entry: Addressing community and structural barriers

Abstract
Persons who experience incarceration are disproportionately impacted by HIV infection. The time of release from
carceral settings, known as community re-entry, is a period of particularly high risk for persons with HIV. During
this time, people are at an increased risk of viral rebound due to poor ART adherence, substance use relapse,
inability to engage with community HIV providers, inability to fill ART prescriptions, and competing needs in the
chaotic environment to which individuals return. Long-acting injectable (LAI) ART is a new alternative to help
overcome the challenges of adhering to a daily regimen of oral medication. However, little is known about how
best to develop and optimize LAI ART interventions in this population. Therefore, we propose exploratory
implementation research that will provide additional preliminary data to enhance our understanding of LAI ART
implementation in diverse Ending the HIV Epidemic (EHE) areas in the mid-Atlantic region: Prince Georges
County, MD; and Washington, DC. Using the Consolidated Framework for Implementation Research—a
theoretical model that guides investigation into the factors that influence implementation, we propose
interviewing stakeholders in each of the above EHE areas and conducting a Delphi study. Specific focus will be
placed on linkage to a broad array of health services (e.g., mental health, substance use, the need for peer or
community health worker services) and the structural barriers that might be present in each location (health
insurance, housing, employment, poverty). Our specific aims are to: 1) identify how to optimize future LAI ART
interventions in community re-entry populations by interviewing 15 stakeholders at each site (total n=45), and 2)
co-produce best practice guidelines for future LAI ART interventions by conducting a Delphi study with 30
experts. The proposed project maps onto the objectives of the funding announcement in that we will conduct
implementation research to develop a LAI intervention that addresses multi-level factors that are key to
facilitating linkage to innovative HIV treatment modalities. Findings from the supplement supported research will
be the foundation of a future R01 application and, importantly, will be shared back with our EHE implementation,
governmental, and community partners at each EHE site.

Public health relevance
Project Narrative Persons who experience incarceration are disproportionately impacted by HIV. Yet, little is known about how to develop Long-Acting Injectable (LAI) ART during incarceration and after release. We propose research to enhance understanding of LAI ART implementation in diverse Ending the HIV Epidemic areas.